Inhibition of lipoprotein synthesis in Helicobacter pylori

Project Summary Helicobacter pylori is a Gram-negative bacterium that colonizes the stomach in about 50% of
the human population (i.e. over 4 billion people). Without antibiotic therapy, H. pylori can persist in the stomach
for decades. Over time, H. pylori can lead some infected individuals to develop severe diseases including peptic
ulcers or gastric cancer, the third leading cause of cancer-related death worldwide. This has led the World Health
Organization (WHO) to classify H. pylori as a type I carcinogen. The effectiveness of therapeutic approaches is
becoming increasingly compromised by the growing incidence of antibiotic resistance, leading WHO to declare
H. pylori a priority pathogen for development of new antimicrobials. Bacterial lipoproteins are modified by
acylation to anchor them to the inner or outer membrane in Gram-negative bacteria where these proteins carry
out a variety of essential functions. The proteins responsible for lipoprotein synthesis and proper subcellular
localization are emerging targets of antimicrobial development. In previous studies, we identified the enzymes
responsible for lipoprotein synthesis in H. pylori. Although the H. pylori proteins only exhibit 20-40% amino acid
identity to their E. coli counterparts, each was able to complement an E. coli mutant strain. In the current
proposal, we hypothesize that inhibitors of H. pylori lipoprotein synthesis would interfere with the ability of H.
pylori to survive in the stomach. This hypothesis is based on the following. First, we found that five proteins
required for lipoprotein synthesis and localization (biogenesis) are essential for H. pylori growth in vitro. Second,
we found that a sixth lipoprotein biogenesis protein (not essential in vitro) is essential for the ability of H. pylori
to colonize the stomach. The current proposal aims to develop assays suitable for high-throughput screening to
identify inhibitors of lipoprotein synthesis in H. pylori. In Aim 1, we will develop complementary assays to monitor
both acylation of a synthetic peptide by recombinant H. pylori prolipoprotein diacylglyceryl transferase (Lgt) and
a byproduct of the acylation reaction. In Aim 2 we will develop an assay to monitor signal peptide cleavage by
recombinant H. pylori lipoprotein signal peptidase (LspA). In Aim 3, we will develop complementary assays to
monitor both acylation of a synthetic peptide by recombinant H. pylori apolipoprotein N-acyltransferase (Lnt) and
a byproduct of the acylation reaction. The assays developed in this R21 Exploratory/Developmental proposal
will provide the foundation for the future identification of inhibitors of H. pylori lipoprotein biogenesis using
computationally driven virtual screening, fragment-based lead discovery, and traditional high-throughput
screening. We will then optimize the activities of identified compounds, determine whether the inhibitors are
specific to H. pylori or are active against other bacteria, and test the effectiveness of inhibitors using established
animal models of H. pylori infection.

Public health relevance
Project Narrative (Relevance to Public Health) Helicobacter pylori can be eradicated from the stomach, reducing the incidence of diseases including ulcers and gastric cancer. However, increasing antibiotic resistance among H. pylori strains is reducing the effectiveness of current treatment regimens. A long-term goal of this research is the development of new therapeutics to treat H. pylori infection.